Forward Genetic Analysis of Cortical Circuits and Structure

The mammalian neocortex is a vast cell network with thousands of connections and is susceptible to numerous
genetic congenital brain anomalies impacting cortical structure and connectivity. This application leverages
forward genetics in mice to identify new genes influencing forebrain neurodevelopment with a specific focus
on cortical structure, lamination and axonal pathways. The cerebral cortex and the basal ganglia comprise the
two major telencephalic brain regions controlling voluntary movement and intellectual capacities. Our
rationale is that by taking an unbiased, forward genetic approach we will uncover new and fundamental
discoveries in the genetics of development and neural circuit formation in these two telencephalic brain
regions. The major outcome of this proposed research is gene discovery to study both typical
neurodevelopment and neuropathology. We will find novel genes which control the formation of forebrain
structure and circuits through the use of ENU mutagenesis in mice carrying genetically encoded reporters
expressed at early stages of neural development, a novel application of these existing genetic tools to a basic
neuroscience question. By completing these studies, we will be positioned to use this information together
with the newly developed tools to develop novel hypotheses concerning the etiological mechanisms of
mammalian forebrain development and neural circuit formation. We will accomplish the goals of this
application by pursuing the following two specific aims: 1) Identify novel genes responsible for proper gross
cortical development, lamination, and layer-specific axonal trajectories and 2) Identify novel genes responsible
for proper development of the internal capsule and the corticospinal tract. The aims are accomplished through
an ENU mutagenesis approach in the mouse. The mutations are then cloned and validated through a number
of functional studies. These studies will identify several genes essential for mammalian forebrain structure and
function and thus linking genetics to neural phenotypes. The significance of this work is found in the specific
application to cortical structure and circuitry, and that an unbiased approach such as this has the capability to
implicate entirely new pathways in neurological disease. Such knowledge is not only critical to further
understand the basic mechanisms of neurodevelopment, but also has immediate clinical relevance through
identification of a number of potential therapeutic targets. Furthermore, these mouse models are novel genetic
tools which provide a reusable resource to directly characterize the role of the mutated gene in
neurodevelopment, and potentially serve as a tool to test future therapeutic interventions. Taken together,
these findings are therefore applicable to basic developmental neurobiology, pediatric and adult neurology,
human genetics and genetic counseling.

Public health relevance
NARRATIVE Birth defects affecting the structure of the mammalian nervous system are fairly common (~15/10,000 births). While these congenital defects have a genetic component, the precise genes responsible are still largely unknown. This proposal will use genetic approaches with emerging sequencing and animal transgenic technologies to study the etiology of defects in cortical development with an additional focus on circuit formation and function and lead to more effective clinical genetics, diagnostics, and therapeutic interventions.